Fort Belknap - JHU NARCH XI Administrative Core

PROJECT SUMMARY
The goal of the Fort Belknap Community (FBC)-Johns Hopkins University (JHU) NARCH XI
Administrative Core is to coordinate functions across the 3 NARCH projects proposed in this
application, including: (1) Student, Tribal Health Leader and Faculty Development Project that
will integrate academic and field-based research training, and adaptation and evaluation of a
Mental Health Training Program for nurses, and, (2) two NARCH research projects to (a)
develop strategies to reduce the risks and promote healing after a suicide death and to develop
a suicide cluster response plan, and (b) adapt and evaluate an evidence- and technology-based
safety planning intervention, myPlan app, to improve safety and health for with Native American
adolescents in rural settings.
Core administrative functions will include the following: Management and facilitation of two
NARCH XI Tribal Advisory Boards; coordination of communication among proposed
student/faculty and research components; oversight of federal reporting and fiscal management
responsibilities; oversight of data safety monitoring; oversight of confidentiality protections;
oversight of evaluation and long-term strategic planning; continuous development of resources
to expand and sustain the training, mentoring and research initiatives; and dissemination of
information regarding NARCH training and research progress to the Fort Belknap Tribal Leaders
and community and local, regional and national collaborative partners addressing tribal health.